Identifying the impact of ableism on maternal health outcomes among Medicaid-enrolled women with IDD

PROJECT ABSTRACT
The proposed study will conduct a detailed examination of the impact of ableism on women with intellectual
and developmental disabilities (I/DD) during pregnancy and the postpartum period, and will compare outcomes
experienced by this group and their infants to those of peers without I/DD. Despite the growing number of
individuals with I/DD giving birth and the substantial health needs and comorbidities present in this population,
very little is known about the impact of ableism on healthcare access and service use among women with I/DD
in the periods before and after delivery. Examining the healthcare experiences of these women in the Medicaid
system in the US is a critical starting point. Medicaid funds almost half of births in the US and is among the
only healthcare coverage options available to birthing people with disabilities including I/DD, most of whom do
not have access to employer-sponsored health insurance. In addition, the Medicaid beneficiary population is
diverse and includes birthing people from higher maternal risk groups, including Black women and women from
other racial/ethnic minority groups who are disproportionately impacted by mental health diagnoses and
maternal morbidity and mortality. We propose to use the latest available national Medicaid claims data (2016-
2023) to identify women with I/DD between 14 and 50 years of age who have given birth and are at risk for
experiencing ableism and link them to their infants, who are also typically enrolled in Medicaid. We will
compare pregnancy, childbirth, and postpartum health outcomes among women with I/DD compared to women
without I/DD. By linking these women to their infants, we will assess the impact of ableism on neonatal and
post-natal health outcomes, morbidity, and mortality. We will also link Medicaid information to other key data
sources, including Census-based indicators of community-level social determinants of health and state
Medicaid policy data to identify structural ableism and opportunities for systemic intervention. Using Medicaid-
generated data that identifies service providers and designing data collection instruments aimed at assessing
ableism, we will then survey and interview obstetric service providers to identify how attitudinal ableism
impacts barriers and facilitators to service delivery and potentially modifiable components of healthcare
access, referral, and service delivery (e.g., training, preparedness, communication) that may moderate the
relationship between I/DD status and outcomes during pregnancy and postpartum. The information generated
by this study is essential to identifying opportunities to address attitudinal and structural ableism to improve the
system of care to meet the needs of the growing group of birthing women with I/DD and support outcomes for
their infants. Completion of this study will result in the most substantive national work to date to identify
modifiable policy, system, and provider factors to mitigate the impact of ableism and support improved
outcomes for women with I/DD during the pregnancy and postpartum periods and their babies, with the goal of
reducing observed adverse pregnancy and postpartum outcomes among women from underserved groups.

Public health relevance
PROJECT NARRATIVE Despite the growing number of women with intellectual and developmental disabilities (I/DD) giving birth, very little is known about the impact of ableism on their access to healthcare and service use during pregnancy, delivery, and postpartum periods. Using 2016-2023 national Medicaid claims linked to community-level information about social determinants of health, state Medicaid policy data, and other data sources, the proposed study will conduct a detailed examination of service access and delivery to birthing people with I/DD aged 14 to 50 who have experienced a delivery and will compare outcomes experienced by this group and their linked infants to those of their Medicaid-enrolled peers without I/DD. Paired with surveys and interviews of obstetric service providers identified through Medicaid claims, this mixed methods study will result in the most substantive work to date to identify the impact of ableism on birthing people with I/DD at both the clinical care (attitudinal ableism) and system (Medicaid policy, structural ableism) levels.